Criteria for Retriage to Improve Trauma Induced Coagulopathy and hemorrhage Associated Lethality

Project Summary/Abstract
Injury is the most common cause of death in people 46 years of age and younger. Bleeding from injury
(trauma-induced hemorrhage) is the second leading cause of injury-associated death and the most common
cause of preventable death. Annually, 70-100,000 Americans suffer a preventable death from trauma-induced
hemorrhage. These deaths could be prevented were patients to receive timely care (e.g., hemostatic
resuscitation and hemorrhage control procedures within two hours of injury) in hospitals that specialize in injury
care (e.g., high level trauma centers). These high-level trauma centers have the equipment, blood products,
medications, massive transfusion protocols and staff 24 hours a day, 7 days a week to provide hemostatic
resuscitation and hemorrhage control procedures. These resources and services are not available at non-
specialized hospitals. Management of bleeding requires timely procedures to stop the bleeding as well as
medications and blood transfusions to prevent blood from thinning (trauma-induced coagulopathy). Our
previous work demonstrated that the most common reason patients were not quickly transferred (retriaged)
from non-specialized hospitals to another specialized high-level trauma center was because clinicians did not
know who should be retriaged. There are no national retriage guidelines. Our literature review demonstrated
only 22 out of 50 states in the United States have any retriage guidelines. Even among states that have
retriage guidelines, most guidelines are very vague (e.g., hypotension requiring blood transfusions). This
application’s broad, long-term objective is to improve the timeliness of care of trauma-induced hemorrhage. We
propose to comperehensively determine who should be quickly retriaged to specialized high-level trauma
centers, and determine if state-of-the-art approaches to informing retriage decisions could improve timliness of
treatment and reduce death rates. This study’s first specific aim will identify which patients and injuries have
the greatest reduction in death rates upon retriage from non-specialized to specialized high-level trauma
centers using Causal Graphical Models. The second aim will understand which patient injury and context
attributes multi-speciality injury experts prioritize when making retriage choices using Discrete Choice
Experiments. The third aim will determine if a protocol providing retriage decision support [PRotocol for
OpMTimal reTRiage [PROMTR)] could improve time to treatment and death rates compared to usual care
using Discrete Event Simulation. Upon demonstrating efficacy in improved timeliness of treatment and death
rates in this simulation study, our future direction will be implementing and evaluating effectiveness of
PROMTR in a Hybrid Type II Cluster Randomized Controlled Trial. This line of research has high potential to
improve and standardize existing retriage practices, resulting in the reduction of preventable injury-associated
death from bleeding.

Public health relevance
Project Narrative Patients bleeding from injury are infrequently and too slowly transferred (retriaged) from non-specialized hospitals to specialized hospitals, leading to avoidable death. Right now, we do not know which patients bleeding from injury need to be quickly transferred to specialized hospitals, resulting in non-specialized hospitals doing long and unnecessary evaluations that slow transfer to specialized hospitals and delay access to timely bleeding treatments. Better early identification of which patients bleeding from injury need to be quickly transferred to specialized hospitals will improve the timeliness of access to specialized bleeding treatments so that people at risk of bleeding to death from injury have the opportunity to live longer and more fulfilling lives.